Ordered gene knockout libraries for Neisseria gonorrhoeae

Abstract
Neisseria gonorrhoeae is the sole causative agent of the sexually transmitted infection gonorrhea that
is restricted to the human population. N. gonorrhoeae has co-evolved with its human host throughout
all modern history and has evolved specific mechanisms of pathogenesis that relate to its mode of
transmission and the anatomical sites it colonizes. Rates of gonorrhea are rising along with a rapid
acquisition of antibiotic resistance. There is an urgent need to understand of the mechanisms of N.
gonorrhoeae pathogenesis to develop new treatment options or vaccine candidates. N. gonorrhoeae
is naturally competent for DNA transformation and is one of a few bacterial species that does not
regulate competence. This resource grant will leverage the transformation competence of N.
gonorrhoeae and synthetic DNA constructs to create ordered gene knockout libraries of the two most
commonly used N. gonorrhoeae strains, MS11 and FA1090. These strains represent different
phylogenetic clades of the bacterium. The libraries will include deletions of all genes encoding an
open reading frame (ORF) that will allow the replacement of the ORF with a non-polar kanamycin
resistance gene (KmR). Each KmR insertion mutant will also carry a unique random barcode.
Leading researchers in the field and NIAID program officials also support this resource proposal as
an important shared resource to help advance progress in this field.

Public health relevance
Narrative There is a need for rapid advances in understanding the ways the sole causative agent of the sexually transmitted infection, gonorrhea acts as a successful pathogen. This need is due to rising rate of N. gonorrhoeae infection and an alarming rise in antibiotic resistance that is complicating treatment. This work will create genetic resources for the entire research field that will facilitate investigations into how this important human pathogen causes disease and facilitate the development of new treatments or vaccines.